Northwell Health NCORP

Project Summary:
With 35 years expertise providing vital cancer research, the Northwell Health Cancer Institute is applying to
continue as a community site for the National Cancer Institute Community Oncology Research Program
(NCORP). Cancer has been identified as a high priority in our catchment area and, through affiliations with the
various NCORP Research bases, our site is able to bring cancer clinical research to the populations in our
community. In alignment with NCORP goals, the Northwell Health NCORP will continue to: 1. provide patients
access to national cancer control, prevention, treatment, and care delivery studies, 2. engage with
underrepresented populations to reduce health disparities and increase health equity, and 3. identify significant
concerns raised by our unique local populations. As the program continues, our community site will enhance
relationships with all Northwell Health Divisions and strengthen communication between primary and sub-
affiliate sites. The Northwell Health Cancer Institute, including 9 NCORP performance site, is a multi-faceted
program which treats approximately 14,000 patients with cancer annually. Since the inception of the new
NCORP in 2014, over 300 patient have been accrued to NCI sponsored trials adding to the broad evidence
base which contributed to improved patient outcomes.

Public health relevance
Project Narrative: The most recent community needs assessment denoted cancer as the most significant health priority in Nassau and Suffolk Counties and the second most significant in Queens County. Strategies to decrease cancer burden were identified and included increased outreach and leveraging education and wellness programs to all communities; diverse, underserved, and anyone in our catchment area. With our current system in place Northwell Health NCORP can affect change on health outcomes in the community.